Learning in Two Languages by Bilingual Children With and Without Language Impairment

Project Summary/Abstract
Bilingualism is the norm for much of the world, and even in the United States, where monolingualism is common,
at least 22% of individuals over age 5 speak a language other than English at home. However, we still do not
know how to best structure the language environment to yield optimal language outcomes in bilingual children.
In the current proposal, we aim to answer this fundamental question by examining the effect of dual language
input on word learning in Spanish-English bilingual children with fluctuating levels of language ability. Specific
Aim 1 is to examine the effect of dual language input on novel word learning. In these experiments we will
contrast learning from single-language (English only) vs. dual language exposure (Spanish and English) across
different types of dual-language input and for different word types. Specific Aim 2 is to examine the effect of
dual language input on novel word consolidation. In these experiments, we will use eye-tracking to test whether
newly-learned novel words enter into interactive dynamics with known words within and across languages.
Specific Aim 3 is to examine the relationship between language ability and novel word learning under dual-
language conditions. We will do so by recruiting bilingual children who occupy the full range of language abilities
- from typical skills in both English and Spanish to weak skills in both languages (i.e., language impairment). This
strategy will enable us to treat language ability as a continuum and to examine how it predicts novel word learning
and consolidation across all experiments proposed under Aims 1 and 2. We hypothesize that dual-language
input may be particularly challenging for children with weak language skills, and expect that the relationship
between language ability and word-learning outcomes will vary across different types of dual-language input and
different word types. Ultimately, we will be able to state whether children with weak language skills struggle more
with learning from dual-language input than children with strong language skills, yielding practical
recommendations for parents, clinicians, and educators. Together, our findings will have clear-cut practical
consequences and far-reaching theoretical ramifications. Currently, advice to parents raising bilingual children
with language impairment regarding the optimal language exposure is based on intuition rather than on solid
empirical evidence. The current proposal represents the first step towards establishing empirically-grounded
guidelines regarding optimal language input for bilingual children with and without language impairment. At the
theoretical level, the study of code-switching has been central to the field of bilingualism, and we know a great
deal about the process by which bilinguals switch languages. However, we know very little about how the
different ways of switching languages influence children’s ability to learn. By focusing on the learning process
itself, the proposed project can contribute vital information to the code-switching literature, while at the same
time shedding light on how dual language input may shape lexical learning.

Public health relevance
Project Narrative Bilingual children are exposed to two languages; however, the effect of such dual language input on language learning is unknown. It is also unknown whether the strength of the language system mediates the effects of dual-language input on learning. Therefore, this project examines how dual language input influences the learning of words in bilingual children who span the continuum of language abilities – from those with typical skills in both languages to those with weak skills in both languages (i.e., language impairment).